Development of evolutionary technologies to reprogram protein-protein interactions

Project Summary
Alterations in protein-protein interactions (PPI) can result in dysregulated biological signaling. PPIs are critical
drivers of a plethora of disease states and are increasingly recognized as important therapeutic targets.
However, PPIs have been difficult to target with traditional therapeutics, and are often considered
“undruggable”, because traditional small molecule discovery strategies are not well suited to identify molecules
with suitable properties to disrupt PPIs. When a disease-associated PPI target is identified, translating that
information into a validated molecular probe can take years, development of a clinically useful therapeutic can
take decades, and even worse, in most cases these efforts fail entirely. The costs associated with developing
therapeutic leads limits pursuits towards only thoroughly validated targets. A faster, less expensive, and more
efficacious pipeline for PPI inhibitor discovery would allow researchers to quickly identify probes for directly
perturbing PPIs in relevant model systems to assess the validity of the PPI as a therapeutic target and to
generate candidate inhibitors for clinical development. While almost all areas of basic and translational biology
research have benefitted from 21st century technological advances in genetic sequencing, mass spectrometry,
and other diagnostics, drug discovery still largely relies on 20th century methods, which have proven to be
frustratingly slow and unsuccessful in critical ways—our proposed technology aims to solve these problems.
We hypothesize that continuous evolution techniques will allow us to rapidly evolve PPI inhibitors for a wide
range of cytosolic protein targets. Specifically, we will pursue two key advancements to realize this broad goal.
In Aim 1, we will demonstrate that non-continuous selection followed by phage-assisted continuous evolution
(PACE) allows us to rapidly evolve protein binders for diverse proteins using a library-of-libraries approach.
This approach will eliminate a crucial bottleneck in PACE, optimization of initial selection stringency, and bring
PACE much closer to automated plug-and-play allowing for broader adoption of this technique. In Aim 2, we
will construct and validate a PACE compatible biosensor linking disruption of a specific PPI to phage fitness
allowing for us to directly select for PPI inhibitor function. Our goal is to demonstrate generation and validation
of high potency PPI inhibitors for a given target in under 1 month. We will validate these evolution platforms
using three well-studied oncogenic protein-protein interactions that have been the focus of small molecule drug
development for decades: MDM2-p53, KRAS-RAF, and Myc-MAX. While this is a lofty goal, the power of
evolution has long been recognized as a promising solution to this problem; we are hopeful that by merging
innovative biosensor designs and continuous evolution, we can unlock the full potential of laboratory evolution.
If successful, these platforms have the potential to revolutionize the drug discovery paradigm and accelerate
the discovery of novel PPI inhibitors.

Public health relevance
Project Narrative This project aims to transform the study of protein-protein interaction networks, which is the foundation of all biological signaling. By developing a technology for the rapid, inexpensive, and efficacious evolution of protein- protein interaction inhibitors, testing of potential therapeutic protein-protein interaction targets can become routine. This new evolution-based technology will have broad applications in basic cell biology and the study of biological signaling and will open new therapeutic opportunities.